Characterizing the role of mitochondrial DNA mutations on retinal degeneration.

PROJECT SUMMARY:
Retinal cell health is a vital aspect of ophthalmic biology allowing us to see the world around us every day.
Degeneration of the retina and/or retinal pigment epithelium (RPE) is a central cause of numerous clinical eye
disorders such as age-related macular degeneration, retinitis pigmentosa, or glaucoma. Recent investigation
into disease etiology has implicated oxidative stress and mitochondrial dysfunction as key players in the initiation
of an unhealthy retina. More specifically, analysis of primary tissue from human donors have shown increases
in mitochondrial DNA (mtDNA) mutations in these samples. This study uses novel pre-clinical models to test the
hypothesis that impaired mitochondrial function due to mtDNA damage results in age-related retinal and RPE
degeneration. To address this hypothesis we are utilizing polymerase gamma (Pol γ) as a tool to study the impact
of mtDNA mutation burden on retinal health in both animal and cellular models. Previously developed mutated
versions of Pol γ have shown to drastically increase mtDNA mutation rate, rendering this an effective method to
analyze the impact mtDNA mutations have on specific biological mechanisms. The goal of this proposal is to
determine the contribution mtDNA damage has on the onset and progression of retinal degeneration. This study
will pinpoint how mitochondrial dysfunction and oxidative stress driven by mtDNA mutations promote an
unhealthy state of the retina. Successful completion of this study will not only offer deeper mechanistic
understanding of retinal disease, but may also open a novel avenue for therapeutic targeting.

Public health relevance
PROJECT NARRATIVE: Retinal degeneration is a biological phenomenon that drives the pathology of eye disorders such as age-related macular degeneration, retinitis pigmentosa, and glaucoma. Mitochondrial dysfunction is a major contributor to these degenerative diseases that remains to be more thoroughly investigated. By analyzing specific mechanisms that lead to mitochondrial dysfunction in the retina and retinal pigment epithelium, I hope to better understand disease onset and reveal novel therapeutic targets to improve patient care.